Targeting Hospital-Acquired Complications: Impact on the Care of Complex Patients

DESCRIPTION (provided by applicant): Two major policy approaches are used currently to motivate hospitals to prevent hospital-acquired complications (HACs): 1) public reporting of hospital performance regarding patient safety (e.g., the website Hospital Compare), and 2) value-based purchasing, which ties hospital payment with better patient outcomes, such as the Hospital-Acquired Conditions Initiative implemented by the Centers for Medicare & Medicaid Services (CMS) to stop hospitals from receiving extra payment for specific reasonably preventable complications. This CMS initiative also enables public reporting of HACs by requiring hospitals to identify discharge diagnoses as present-on-admission or not (i.e., hospital-acquired), changing a routinely-generated administrative dataset into a new data source to generate rates of HACs to compare hospitals. Though intended to improve patient safety (and save money), these changes regarding data collection, payment, and public reporting of HACs have occurred without preliminary evaluations concerning: 1) the validity of these new data regarding HAC rates, and 2) what clinical impacts these changes may have on patients. These two knowledge gaps are significant, as public reporting of other patient outcomes (e.g., hospital mortality) has demonstrated that evaluating and reporting outcome data is complicated, and can have both intended and unintended consequences for patients - particularly for complex patients (i.e., with multiple chronic conditions) with higher baseline risks for poor outcomes including HACs. The candidate Dr. Jennifer Meddings, who will focus her research on the growing population of complex patients, will pursue a mentored research plan designed to enhance her skills concerning methods needed to evaluate the clinical impact of quality improvement initiatives for complex patients, with two specific aims: Aim 1. To validate measures of hospital-acquired complications derived from administrative data as indicators of hospital quality, by triangulation with measures from different data sources. Aim 2. To evaluate unintended outcomes (i.e., collateral benefits and damages) for patients as downstream or spillover effects of non-payment and public reporting for specific hospital-acquired complications, with a focus on impacts for complex patients. Using multiple years of patient-level administrative data, Aim 2's analyses will focus on three outcomes that could improve (as collateral benefit) or worsen (as collateral damage) as hospitals respond to non-payment or public reporting for specific HACs: 1) early readmission, 2) level of care after discharge (such skilled nursing facility), and 3) secondary complications, related to developing or treating the initial HAC. This research and advanced coursework will facilitate Dr. Meddings's development into a leading independent investigator in performance measurement and improvement, whose research will inform policy decisions to improve care for complex patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: As the elderly population increases, the number of "complex" patients (i.e., with multiple chronic diseases) is rising dramatically. Because complex patients have higher rates of hospitalizations, with longer lengths of stay and higher rates of hospital-acquired complications, complex patients are perhaps the most important population to assess and monitor the impact of two quality improvement strategies being used to motivate hospitals to decrease hospital-acquired complications: 1) public reporting of hospital performance regarding patient safety (such as the website Hospital Compare), and 2) "value-based purchasing," which ties hospital payment with better outcomes, such as the recently implemented Hospital-Acquired Conditions Initiative by the Centers for Medicare & Medicaid Services (CMS) to stop hospitals from receiving extra payment to treat specific "reasonably preventable" hospital-acquired complications. The proposed research will assess the merit of the new data for complication rates as indicators of hospital quality, and will assess the clinical impacts (intended and unintended) of value-based purchasing and public reporting initiatives for complex patients; this research will provide critical early feedback to the public, clinicians, hospitals, and CMS to reduce unintended harm to complex patients as well as to inform approaches for developing and evaluating future healthcare reforms designed to motivate improved care. As the elderly population increases, the number of "complex" patients (i.e., with multiple chronic diseases) is rising dramatically. Because complex patients have higher rates of hospitalizations, with longer lengths of stay and higher rates of hospital-acquired complications, complex patients are perhaps the most important population to assess and monitor the impact of two quality improvement strategies being used to motivate hospitals to decrease hospital-acquired complications: 1) public reporting of hospital performance regarding patient safety (such as the website Hospital Compare), and 2) "value-based purchasing," which ties hospital payment with better outcomes, such as the recently implemented Hospital-Acquired Conditions Initiative by the Centers for Medicare & Medicaid Services (CMS) to stop hospitals from receiving extra payment to treat specific "reasonably preventable" hospital-acquired complications. The proposed research will assess the merit of the new data for complication rates as indicators of hospital quality, and will assess the clinical impacts (intended and unintended) of value-based purchasing and public reporting initiatives for complex patients; this research will provide critical early feedback to the public, clinicians, hospitals, and CMS to reduce unintended harm to complex patients as well as to inform approaches for developing and evaluating future healthcare reforms designed to motivate improved care. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS: Targeting Hospital-Acquired Complications: Impact on the Care of Complex Patients Two new strategies are being used to motivate hospitals to prevent complications: 1) public reporting of hospital performance in patient safety,35, 36 and 2) "value-based purchasing" programs such as the Hospital- Acquired Conditions Initiative37, 38 which, since October 2008, eliminates extra Medicare payments when any patient develops certain "reasonably preventable" complications. Because complications occur at higher rates for patients with multiple chronic diseases (i.e., "complex" patients),39, 40 it is paramount to assess how complex patients are impacted by these public reporting and value-based purchasing strategies - particularly as the number of clinically complex patients is rising dramatically as our population ages.41, 42 However, the Hospital-Acquired Conditions Initiative is more than a rule change about extra payments. Because it requires hospitals to identify each diagnosis as "present-on-admission" or hospital-acquired, it changes administrative claims data into a new dataset for comparing hospitals by complication rates. This new data enables public reporting of complication rates for hospitals, and is already used to report hospital-acquired pressure ulcer rates.43 It has been suggested that rates of hospital-acquired complications from these data be used to adjust overall hospital payments, by paying less for each admission to hospitals with higher complication rates.38 In contrast to prior measures of complications derived from administrative data44, 45 (e.g., AHRQ's Patient Safety Indicators), the new data about hospital-acquired complications is being used to change payment and report performance without risk-adjustment for patient co-morbidities. Although clearly intended to improve patient safety, these changes involving data collection, payment and public reporting for hospital-acquired complications have occurred without an accompanying framework to validate these new measures of complication rates or to monitor the clinical impact of these changes on patients. These knowledge gaps are significant as public reporting of other patient outcomes (e.g., hospital mortality) demonstrated that evaluating and reporting outcome data is complicated,46 and can have unintended consequences for patients such as increased racial disparities and physician avoidance of the sickest patients47 (e.g., complex patients with higher baseline risks for complications). The proposed research will address these knowledge gaps, through two specific aims: Specific Aim 1: To validate measures of hospital-acquired complications derived from administrative data as indicators of hospital quality, by triangulating with measures from other data sources. Using a novel dataset linking administrative data with publicly-reported measures of hospital performance for specific complications (derived using different data sources), three main hypotheses will be tested using multi-level analyses, focusing on hospital-acquired infections, blood clots, and pressure ulcers: H1a: Hospital-acquired complication rates derived from administrative data will be strongly associated with hospital rates for these same complications derived from other data sources (e.g., medical record review and complication surveillance exams). H1b: Hospital-acquired complication rates will be inversely associated with a hospital's use of therapies to prevent specific complications (i.e., process measures). H1c: Hospital-acquired complication rates will be more strongly associated with hospital use of complication- prevention therapies (process measures) after adjusting for patient characteristics (i.e., co-morbidities). Specific Aim 2: To evaluate unintended outcomes for patients (as collateral benefits or damages48) from the Hospital-Acquired Conditions Initiative. Using cross-sectional and longitudinal designs, these analyses will focus on outcomes important to complex patients, which could improve (as collateral benefit) or worsen (as collateral damage) as hospitals respond to non-payment and reporting of specific hospital-acquired complications. Two hypotheses will be tested: H2a: Development of specific hospital-acquired complications is associated with downstream effects on: 1) need for early readmission,37 2) level of care needed after discharge, and 3) risk of developing secondary complications that are related to the primary hospital-acquired complication. H2b: Decreases in hospital-acquired complications targeted for non-payment or reporting for narrow patient populations (such as post-operative blood clots in orthopedic surgery patients) will be associated with spillover effects on similar complications in broader patient populations (such as post-operative blood clots in other surgical patients, or hospital-acquired blood clots in non-surgical patient populations). Because healthcare reform may promote similar value-based purchasing and reporting strategies, the methods and knowledge produced by this research are vital to advance the science of quality assessment to meet the new challenges these strategies bring. This research will also inform critical policy decisions for applying these strategies, to maximize benefit and mitigate harm - particularly for complex patients.